Statistical Methods to Integrate Rich Functional and Phenotypic Data in Whole Genome Sequencing Analyses

This proposal is a ﬁve-year program to support Dr. Sheila Gaynor's career development in her transition from a postdoctoral fellow to an independent investigator in statistical genetics and genomics, with expertise in whole genome sequencing (WGS) studies of pulmonary traits and lung diseases. Dr. Gaynor has training in compu- tational biology and biostatistics, and is currently a postdoctoral fellow in the Department of Biostatistics at the Harvard T. H. Chan School of Public Health. The proposed aims develop and strengthen Dr. Gaynor's expertise in statistical genetics, pulmonary disease, lung biology, and computing. In this program, she will develop scal- able statistical and computational methods to (1) investigate the role of rare variants in inﬂuencing lung function and conferring lung disease risk with an emphasis on leveraging incomplete phenotypes and (2) ﬁne-map lung function- and disease-associated variants to specify likely biologically causal variants. Lung diseases such as chronic pulmonary obstructive disorder (COPD) are leading causes of morbidity and comorbidity. They have a notable genetic component, but a limited number of associated variants have been iden- tiﬁed and their potential causal or functional roles are not well understood. Current large-scale whole genome sequencing efforts, including the NHLBI Trans-Omics for Precision Medicine (TOPMed) Program, allow for the in- vestigation of complex disease genetics in unprecedented ways across heart, lung, blood, and sleep phenotypes. Aim 1 of this proposal is to develop a statistical and computational framework for testing rare variant associations with one or more phenotypes, where phenotypic data is limited but functional data is available. Aim 2 of this proposal is to develop computationally efﬁcient statistical ﬁne-mapping methods to identify likely causal variants using functional data, such as tissue-speciﬁc and cell-type speciﬁc features. Dr. Gaynor will apply these methods to data from the TOPMed Program to study pulmonary function and COPD. Aim 3 is to develop software for the efﬁcient and open-souce implementation of the statistical methods in Aims 1 and 2. In the K99 phase, Dr. Gaynor will be mentored in statistical genetics by Dr. Xihong Lin, Professor of Bio- statistics and of Statistics, with a focus on statistical methods for powerful inference, mixed models, and missing data. She will be co-mentored by Dr. Edwin Silverman, Division Chief at Brigham and Women's Hospital, in pul- monology, genetic epidemiology, and collaborative WGS efforts. The training in this phase will include structured mentorship, collaborative research in the TOPMed Program, coursework in pulmonology and computer science, scientiﬁc seminars and conferences, and training in grant writing, communication, and leadership skills to support career and professional development. With the skills acquired in the K99 phase, Dr. Gaynor will transition to a new institution during the R00 phase to complete and extend the proposed aims. Upon the completion of this award, Dr. Gaynor will have launched an independent research career towards becoming an interdisciplinary leader in statistical genetics and genomics with expertise in WGS studies of pulmonary disease and lung biology.

Public health relevance
Project Narrative Pulmonary conditions and diseases are a major public health burden and are considerably inﬂuenced by genetic factors. Current statistical and computational methods do not allow for the full use of extensive phenotypic and functional data to elucidate such genetic factors from whole genome sequencing studies. The proposed research will develop statistical and computational methods for powerfully leveraging genomic, phenotypic, and functional data to identify disease-associated rare and causal variants, and provide new insights into the biological mechanisms affecting pulmonary traits and diseases.